Care Coordination for High-Risk Patients with Multiple Chronic Conditions

Background. Care fragmentation is a mounting challenge for Veterans, many of whom face multiple chronic conditions requiring care from different providers and clinics. This issue is likely to intensify in light of a policy environment that increasingly encourages Veterans’ dual use of VA and community care. When patient care is dispersed across providers, clinics, and health systems, it increases risks of information loss, medication interactions, and unwieldy treatment regimens, leading to health deterioration. Veterans in poor health and those with functional limitations or resource constraints may be especially vulnerable, yet little is known about fragmentation patterns and care coordination needs in these high-risk patients. Project Objectives. The objective of this study is to advance understanding of care fragmentation and care coordination’s potential among high-risk Veterans with multiple chronic conditions. Project Methods. To achieve the study goals, we will first describe care fragmentation prevalence and variation in a national cohort of high-risk patients (Aim 1). We will then examine the relationships between care fragmentation and outcomes, including acute care utilization (Aim 2.1) and patient-reported care experience (Aim 3.1). Finally we will evaluate whether randomization to comprehensive care coordination mitigates the effects of fragmentation (Aims 2.2 and 3.2). ? Aim 1. We will use 2014-2015 VA, VA purchased care (including Veterans Access, Choice, and Accountability Act), and Medicare data from a national sample of high-risk patients (Care Assessment Needs hospitalization risk score ≥ 90th percentile). In Aim 1.1, we will describe primary care, outpatient care, and health system fragmentation, using validated and adapted measures of care fragmentation and discontinuity. Using a theoretical approach to compare measures, we will select a primary fragmentation measure within each domain for use in subsequent aims. In Aim 1.2, we will use these select measures to examine variation in care fragmentation by patient characteristics (e.g., age, sex, chronic conditions, housing instability, distance from VA, and enrollment in care coordination programs). ? Aim 2. Using select fragmentation measures identified in Aim 1.1, we will evaluate the relationship between care fragmentation and acute care utilization among high-risk Veterans. In Aim 2.1, we will determine whether care fragmentation is independently associated with higher rates of acute care utilization (including emergency department visits and hospitalizations). In Aim 2.2, we will take advantage of an ongoing randomized evaluation of an Office of Primary Care PACT-Intensive Management (PIM) Demonstration Program to test whether comprehensive care coordination influences the relationship between fragmentation and acute care outcomes. ? Aim 3. In Aim 3, we will analyze findings from an operations-supported survey administered to high-risk patients in the PIM Demonstration Program to examine the relationship between care fragmentation and patient experiences with care. In Aim 3.1, we will assess whether greater fragmentation is associated with low satisfaction, poor perceived care coordination, and patient-reported challenges with access, communication, and self-management. In Aim 3.2, we will examine whether comprehensive care coordination offered through PIM influences the relationship between fragmentation and patient experience. Study findings will advance understanding of high-risk Veterans’ care fragmentation, associated outcomes, and their potential benefit from intensive care coordination. The study will also inform program development and generate care fragmentation measures for our operations partners in VA’s Offices of Primary Care, Access to Care, Community Care, Geriatrics and Extended Care, and Women’s Health Services.

Public health relevance
Veterans are increasingly facing care fragmentation, a challenge that will likely intensify in a policy environment which encourages Veterans to use both VA and community care. Veterans who are at high- risk for hospitalization and individuals with functional limitations or resource constraints may be especially vulnerable to negative consequences from fragmented care. The proposed work will 1) describe care fragmentation prevalence and variation among a national sample of high-risk patients in the VA Health Care System, 2) determine the relationship between care fragmentation and important clinical and patient- centered outcomes, and 3) evaluate the effectiveness of comprehensive care coordination interventions for patients with fragmented care. Our findings will inform both current and future efforts to improve and streamline care for high-risk Veterans with multiple chronic conditions.